Small molecule inhibitors of cariogenic biofilms

Abstract
Dental caries (tooth decay) is the most prevalent infectious disease afflicting American Public. Biofilm
formation is crucial for the development of dental caries induced by cariogenic bacteria. Streptococcus mutans
is a model cariogenic bacterium that has adapted to the biofilm lifestyle. Bacteria within a biofilm are extremely
resistant to traditional antibiotics and host defense; therefore development of new classes of anti-biofilm reagents
that interfere with the biofilm formation and development by cariogenic bacteria is necessary and critical for the
treatment and prevention of dental caries. The most potent and versatile class of molecules with anti-biofilm
properties are those derived from the 2-aminoimidazole (2-AI) scaffold discovered by the Melander group from
natural marine products. The 2-AI derivative is capable of inhibiting and dispersing diverse biofilms formed by
Gram-negative and Gram-positive bacteria. In the last funding cycle, we have made great progress, and
identified and characterized two distinct 2-AI derivatives that either inhibit or disperse S. mutans cariogenic
biofilms specifically. The lead compounds do not affect biofilm formation by commensal oral streptococci. Our
studies have shown that one 2-AI derivative selectively targets a response regulator that modulates S. mutans
biofilm, fitness and virulence. The compound inhibits biofilm formation in vitro and bacterial virulence in vivo in
the complex microbial community, indicating it has great therapeutic potential. Another derivative we identified
selectively disperses preformed S. mutans biofilms in vitro and inhibits bacterial colonization and virulence in
vivo. The dispersion activity is not mediated by any known biofilm pathway, suggesting a novel underlying
mechanism. The goal of our current proposal is to further explore these two new classes of small molecules,
define their modes of action and develop more potent, selective chemical probes to dissect small molecules-
directed gene regulation and signaling that are key to biofilm development. Two specific aims are proposed:
Specific Aim 1: Explore molecular mechanisms of selective targeting of the response regulator of cariogenic
bacteria by the 2-AI derivative and use both structure-activity relationship studies, and structure-based drug
discovery schemes to enlighten the design and the development of more potent and selective chemical probes
to enhance anti-cariogenic activity. Specific Aim 2: Identify molecular targets of the potent small molecule that
disperses cariogenic S. mutans biofilms and determine the underlying mechanism of the biofilm dispersion. An
interdisciplinary team among microbiologists, medicinal chemists, structural biologists, animal model experts,
and dentist scientists will continue their productive collaborations, which should unravel molecular mechanisms
how lead compounds selectively inhibit and disperse cariogenic biofilms and facilitate the development of new
anti-caries strategies. The application will have a direct impact on the oral health of the general public since the
lead compounds have great therapeutic potentials in preventing or treating dental caries.

Public health relevance
NARRATIVE Dental caries (also known as tooth decay or cavity) is the most prevalent infectious disease of mankind. Our proposal will develop new classes of small molecules that selectively inhibit and disperse cariogenic biofilms. The new small molecule leads can be used as chemical probes to explore bacterial fitness and virulence mechanisms, and developed into effective therapies combating and preventing cavity, which will revolutionize age-old treatment options.